Unraveling and counteracting immunoinhibitory signals of the tumor microenvironment for improved cancer immunotherapy

Project summary/Abstract
Macrophages are considered a double-edged sword for tumor cells due to their plasticity in response to
different environments. M1-like macrophages (M1) promote immune responses and inhibit tumor growth, while
M2-like macrophages (M2) contribute to tumor progression by promoting angiogenesis and suppressing T cell
responses. Tumor-associated macrophages (TAMs) predominantly consist of M2 macrophages, creating an
immunosuppressive tumor microenvironment (TME). However, the mechanisms regulating macrophage
polarization within tumors remain poorly understood. Tumor endothelial marker 8 (TEM8) has emerged as a
key biomarker expressed on immunosuppressive cancer-associated fibroblasts (CAFs). Disruption of the Tem8
gene or blocking TEM8 protein has been shown to critically impede tumor growth in mouse models. My
preliminary data demonstrate a striking increase in the M1 population within Tem8 knockout (KO) mice
compared to wildtype (WT) mice. Notably, through an unbiased high-throughput CRISPR/Cas9 activation
library screening, I recently identified TEM8 as a cell surface ligand for a macrophage receptor known as
TEM8R, which plays a crucial role in regulating macrophage polarization. Moreover, TEM8 induces
degradation of TEM8R through trans-endocytosis. Intriguingly, in vivo studies have demonstrated that
monoclonal antibodies (mAbs) targeting TEM8, which effectively block the TEM8-TEM8R interaction, can
inhibit tumor growth. Building upon these findings, my hypothesis is that TEM8 facilitates tumor growth by
modulating macrophage differentiation in the TME through its interaction with TEM8R.
To address this hypothesis, I will first elucidate the role of TEM8R in macrophage polarization within the
TME by using the Tem8r KO mouse model I recently created. Subsequently, I will investigate the impact of the
TEM8-TEM8R interaction on macrophage polarization and tumor growth using mAbs that specifically block this
interaction, as well as a Tem8 mutant mouse model that is defective in this interaction. Furthermore, I will
investigate the underlying mechanisms by which TEM8R regulates macrophage polarization and identify the
factors governing TEM8R expression during macrophage differentiation. Additionally, I will explore the potential
of anti-TEM8R mAbs and small molecule drugs that can disrupt the TEM8-TEM8R interaction as innovative
approaches for cancer treatment and chemoprevention. Through unraveling the mechanisms by which TEM8,
present on tumor-associated stromal cells, regulates TAM dynamics, these studies have the potential to
advance our understanding of immunosuppression in solid tumors and facilitate the development of innovative
and effective therapeutic strategies for cancer treatment and prevention.

Public health relevance
Project Narrative M1-like macrophages can activate immune responses and block tumor growth, while M2-like macrophages are immunosuppressive and promote tumor progression. Unfortunately, M2-like macrophages are predominant in established solid tumors for cancer progression, yet the molecular mechanisms driving macrophage polarization have not been fully elucidated. This proposal aims to decipher the biological role of tumor stromal cells in macrophage differentiation and tumor growth, with important implications for developing improved immunotherapies targeting solid tumors.